Biostatistics and Computational Biology

PROJECT SUMMARY CORE 2
The Biostatistics and Computational Biology Core (Core 2) will be highly integrated with each individual P01
Project, the Administrative Core, and the Sample Processing Core (Core 1) by facilitating the management,
analysis, and sharing of data derived from leukemia patient specimens, mouse models, and cell line models
utilized in this proposal. Core 2 will support this P01 program using infrastructures and collaborative interactions
that are largely pre-existing and will build additional infrastructure as needed to meet the Program Project goals.
The overall goal of the Biostatistics and Computational Biology Core is to provide each Project with
analytical, bioinformatical and statistical expertise for all data generated as part of this Program and to help
discover and validate clinically meaningful biomarkers and novel therapies. Core 2 will assure that the design,
conduct, and analyses of all experiments—clinical, correlative, animal, or basic science—use robust statistical
techniques that are appropriately implemented. To achieve this goal Core 2 will implement state-of-the-art
algorithms and analytical approaches to support discovery of biologically and clinically meaningful signals from
transcriptomic and epigenetic data from cell and mouse models of leukemia. The Core will interface directly with
the Core 1 to provide extensive statistical assessment of biospecimens, as well as with Core 3 for the integration
and clinical translation of all findings. The Biostatistics and Computational Biology Core additionally provides
mechanisms for effective data sharing to enable higher-level integration and synergy across Program Projects
in collaboration with the Administrative Core and the Clinical Research Support Core (Core 3).

Public health relevance
PROJECT NARRATIVE CORE 2 The goal of the Biostatistics and Computational Biology Core (Core 2) is to assure that all experiments conducted through this P01 in myeloid malignancies have access to state-of-the-art statistical and computational support for their design and analysis. This extends to the basic science and murine experiments described in the four Projects, as well as to the clinical and correlative studies undertaken in conjunction with the Clinical Research Support Core (Core 3) and the Sample Processing Core (Core 1). This assures that the work performed on this P01 will be robust and reproducible, and thereby contribute to an improved understanding of these diseases.